Investigating the mechanisms for mutant p53 stability in cancer cells

Project Summary
p53 is a transcription factor that plays a crucial role in tumor suppression, and it is frequently mutated in
human cancers. Missense mutations in the DNA binding domain of p53 can result in a gain-of-function
phenotype, leading to increased cell proliferation and tumor formation. While mutations in other tumor suppressor
proteins such as RB1 and NF1 are deletion mutations leading to decreased protein expression, point mutations
in p53 lead to increased p53 stability and prolonged half-life. In order to improve and develop novel treatments
for cancers containing mutant p53 (mtp53), its mechanisms for increased stability and accumulation in tumors
needs to be largely expanded. Specifically, whether mtp53 requires critical interacting proteins or
posttranslational modifications for its increased accumulation and gain-of-function effect remains to be
elucidated. Most work in identifying novel interactors or modifications on mtp53 has relied on targeting specific
signaling pathways that modulate p53 activity. However, mtp53 is regulated by a wide array of external signals,
so a comprehensive and unbiased approach in studying its regulation is crucial in understanding its mechanisms.
Therefore, this proposal aims to utilize a quantitative mass spectrometry-based approach in identifying
interactors and modifications across different mtp53 mutations and cancer types. This proposed research will
reveal a new layer of information that will aid in determining mechanisms of mtp53 stability, and it will lead to the
discovery of novel targets for cancer therapeutics. This proposal elucidates the mechanisms of mtp53 through
two Aims: (1) Identifying and validating mtp53 interactors across multiple cancer cell lines harboring GOF mtp53
using immunoprecipitation coupled to mass spectrometry, and determining whether the candidate “stabilizers”
are essential for cancer growth using CRISPR gRNA screening approaches. (2) Identifying combinatorial
posttranslational modifications essential for mtp53 stability by developing a quantitative mass spectrometry
method for mtp53. Overall, these aims will shed light on the mechanisms of mtp53 stability in human cancers,
which will offer promising therapeutic targets in cancer.

Public health relevance
Project Narrative While p53 is a major tumor suppressor protein, point mutations within its DNA binding domain causes p53 to become oncogenic due to its increased stability and accumulation in the nucleus. Since mutant p53 can be stabilized by changes in posttranslational modifications (PTMs) or altered interactions with binding partners, I propose to utilize an unbiased quantitative mass spectrometry-based approach to identify and investigate interacting proteins and PTMs critical for the stability of various p53 mutants. As mutant p53 stability is crucial for its tumorigenic effect, interrogating its stability by inhibiting interacting proteins or PTMs offers promising therapeutic targets for human cancers with p53 mutations.